An air-liquid interface system to study Bordetella pertussis interactions with respiratory epithelia

Bordetella pertussis, the bacterial pathogen responsible for “whooping cough” causes an
estimated 24 million cases of vaccine-preventable illness per year, resulting in an excess of
170,000 deaths annually. Importantly, the incidence of whooping cough in nations with high
vaccine coverage is on the rise, attributed to asymptomatic transmission that is enabled by the
imperfect and waning immunity of current acellular pertussis vaccines. Due to these and other
factors, both the CDC and NIH have listed B. pertussis as a priority (re)emerging pathogen of high
concern. B. pertussis efficiently colonizes and grows within the human respiratory tract,
requiring that it access and cross mucus and sol layers to find, tightly attach to and grow on
ciliated epithelial cells. These abilities are critical to its remarkable success, but are difficult
to study in detail in vivo. They have been studied primarily in submerged cell culture, with
monolayers of host cells and B. pertussis all submerged in rich mammalian cell growth media.
These conditions do not replicate the structure or function of the columnar airway epithelia
and completely lack the overlying mucus, sol and air-interface of a natural airway, and the
milieu in which B. pertussis naturally grows. Our team has decades of experience with
Bordetella spp and with polarized primary culture from human broncho-tracheal tissues which
contains representative cell types, most importantly including cilia beating within protective
mucus and sol layers. Here, for the first time, we will use this air-liquid interface (ALI) system,
combined with techniques in genetics and biology of B. pertussis, to probe the roles of key
bacterial factors in host-pathogen interactions with realistic human respiratory epithelia.
Specifically, we propose three aims to (1) identify factors that mediate infiltration through
mucosal layers and enable bacterial growth on ciliated epithelia, (2) define the effect of B.
pertussis factors on inducing and/or modulating epithelial cell produced pro/anti-inflammatory
signals, and (3) determine how B. pertussis damages cells and disrupts the epithelial barrier.
The data generated from these studies will reveal the roles of specific B. pertussis factors in
various measurable aspects of their interactions with ciliated respiratory epithelia and should
inform the choice of new vaccine targets capable of interrupting the airway interactions.

Public health relevance
Narrative Bordetella pertussis resides within airways attached, often in large numbers, to cilia of columnar epithelia and awash in the mucus and sol that overly respiratory epithelia. Attempt to study its attachment and interactions with host cells have been in the context of cells and bacteria all submerged in a very rich growth media, and often result in the death of the host cells. Here we utilize a realistic air-liquid interface in vitro system in which bacteria must cross mucus and sol layers to reach fully differentiated complex epithelial tissue, in which they demonstrate behaviors substantially different from the submerged culture system.